HIV Co-morbidities Research Training in Ghana (HIV-ComRT)

Project Summary
The proposed HIV Comorbidities Research Training (HIV-ComRT) in Ghana builds and expands on our
ongoing successful short-term (8 weeks) summer intensive mentored-research training—the Ghana Research
Scholar Program—at Yale for trainees from Ghana since 2007. The aim of the Ghana Research Scholar
Program is to build and strengthen biomedical research capacity in Ghana; this aim dovetails with the
overarching aim of the Funding Opportunity Announcement (PAR-19-283; Fogarty HIV Research Training
Program for LMIC Institutions). The components and content of the training program were informed by a
consultative need assessment with faculty and leadership at the University of Ghana (UG) and other
stakeholders in Ghana (Ministry of Health, Ghana Health Service, and National AIDS Control Program). We
will recruit trainees with MD, Master's, or PhD degrees and equip them with theoretical and applied knowledge
in research methods, skills in designing and conducting research studies, and life-long career coaching to be
successful investigators in HIV-associated comorbidities and coinfections in Ghana. The formal program of
each trainee will vary, depending on his/her prior training and current career plans. The predominant site for
training, either at UG or Yale, will depend on the needs of the trainee, however, all trainees will be exposed to
resources at both institutions. We will provide trainees with: (1) a strong foundation in both research design
and analytic techniques appropriate for clinical, translational, and laboratory-based research; (2) the ability to
conceptualize and analyze research problems critically and with increasing independence; (3) experience in
scientific writing, presenting and publishing research findings; (4) instruction in management of laboratory and
clinical projects; and (5) mentorship in research and career development. These will be achieved through three
Specific Aims: (1) to provide trainees and other junior faculty at UG with theoretical and applied knowledge in
research methods; (2) to equip trainees with research skills through a two-year intensive and mentored
postdoctoral research training in HIV; and (3) to establish and maintain a mentorship plan for trainees at UG to
become independently funded investigators. During the 5-year grant period, we expect to enroll 14 trainees in
advanced degrees (four PhDs and ten Master's (MSc or MPH)) and provide a two-year intensive postdoctoral
research training for five postdocs/junior faculty. In addition, about 200 graduate students, postdoc fellows,
junior faculty, and research scientists at UG will benefit from the research and career development workshops.
The cohort of trainees will have diverse research interests to ensure that we build capacity in team science in
executing cross- and inter-disciplinary research in HIV-associated comorbidities and coinfections. The skills
that they gain through our program of focused didactic training, interactions with a diverse group of scholars in
a multidisciplinary academic community, and a mentored research experience with outstanding scientists (at
UG and Yale) will provide them with the tools for successful research careers in HIV-associated comorbidities.

Public health relevance
Project Narrative Research is needed to develop effective responses to the HIV epidemic in sub-Saharan Africa. This grant will allow US scientists to build partnerships with their counterparts in Ghana to train young and emerging scientists to conduct meaningful research in HIV-associated comorbidities (one of the five research priorities of the NIH Office of AIDS Research) spanning basic science, translational, clinical, epidemiology and behavioral research. The program described in this application contains a mix of long-, medium-, and short-term training that will enhance research capacity and promote public health significant research in HIV-associated comorbidities.